Genome Stability in Glia & Disease

Abstract
Genome stability is essential for human health. This is apparent from the multitude of inherited human syndromes
characterized by defective DNA damage responses. The nervous system is particularly prone to the
consequences of genome damage, and most inherited DNA repair deficiency syndromes involve
neurodegeneration, neurodevelopmental disorders or brain tumors. Defective maintenance of genome integrity
is also increasingly being linked to broader neurologic health issues, including age-related neurodegenerative
events that mar cognitive ability and quality of life. Understanding the mechanistic connections between faulty
DNA damage signaling and human disease is therefore of fundamental biomedical importance. Most studies
dealing with genome instability associated neuropathology focus on neuronal loss, such as the impact on
cerebellar granule or Purkinje neurons associated with various spinocerebellar ataxias. However, other features
of genome instability associated neurodegenerative syndromes include white matter defects, resulting from
oligodendrocyte dysfunction. Given the widespread alterations and reduction in white matter in these diseases,
and that most disease-causing gene mutations are ubiquitously expressed throughout the nervous system, it’s
very likely that other glial populations are also affected. For instance, neuroinflammation linked to astrocyte and
microglia activation also characterize certain diseases caused by DNA repair defects. However, direct
mechanistic studies to reconcile the contribution of glia to the pathobiology of genome instability syndromes are
sparse. The experiments proposed in this application will provide key data illuminating the glial DNA damage
response and how glia contribute to disease pathogenesis. We propose leveraging novel mouse models of
neurodegenerative disease with defective DNA damage signaling to determine the critical DNA strand break
repair pathways that support glial cell function in the mammalian brain. Accordingly, we will evaluate the
oligodendrocyte lineage for DNA damage susceptibility to determine how dysfunction in these glia occur in
human genome instability syndromes. Oligodendrocyte responses to DNA damage will also be assessed using
chromatin architecture as a predictor of genotoxic susceptibility. Finally, the impact of DNA damage on microglia
will be explored in a new model of the neuroinflammatory Aicardi Goutières Syndrome resulting from defective
ribonucleotide excision repair. Collectively, these data will provide critical information regarding the central
mechanisms that maintain the glial genome and how genome instability in these cells contribute to disease
pathogenesis. As effective therapeutic intervention for many neurological diseases is becoming possible, it’s
now critical to understand the full spectrum of degenerative changes that occur. Thus, data from this proposal
will provide an important framework for understanding progressive aspects of neurological disease resulting from
genome instability and will inform therapeutic strategies for treatment.

Public health relevance
Relevance statement A multitude of human diseases result from defects in genome maintenance and are characterized by profound neurodevelopmental abnormalities and neurodegeneration, even brain tumors, illustrating the importance of DNA repair for brain health. Therefore, understanding how DNA repair pathways function in the brain is critical for the development of treatments for these and other diseases. This grant application proposes a research plan to answer gaps in our knowledge concerning a specific cell type in the brain called glia, and how genome damage in these cells contribute to disease processes.